Metapangenomics of the Oral Microbiome

Project Summary/Abstract
The oral microbiome is a complex multispecies ecosystem. Deciphering the interactions of microbes with each
other and their host habitats is essential for understanding the oral microbiome's role in health and disease and
for developing preventive and therapeutic strategies. To successfully modulate the microbiome we need to
understand the genomic drivers of bacterial site tropisms and community membership. Much of the molecular
data needed to address these fundamental questions already exists in publicly available databases, but has not
been analyzed within an ecologic framework using appropriate bioinformatic tools and in sufficient depth. While
genome information exists for most bacterial species in the mouth, there has been no systematic analysis of
what genes are core or accessory for the major species – information critical for assessing microbial function
and for selecting strains for in vitro models. The scientific premise of our proposal is that the combination of
pangenomic analysis with oral metagenomic information, hence metapangenomics, will test the site-specialist
hypothesis and provide unique, gene-level insights into the function of the oral microbiome.
We will construct pangenomes from high-quality genomes in the National Center for Biotechnology Information
(NCBI) to identify core and accessory genes of oral species. We will map metagenomic data from the Human
Microbiome Project (HMP), and other sources, onto the pangenomes to assess which genomes actually occur
in the human mouth. Analysis by oral site will identify site-tropisms at the genomic level, thus evaluating the site-
specialist hypothesis. We will determine which genes are unique to a species or strain occupying a particular
oral niche, and we will identify candidate gene drivers of site tropism. The products of our analysis will be made
available to the oral research community by expanding the Human Oral Microbiome Database (HOMD),
developed by Dr. Dewhirst, a PI on this proposal. Pangenomes will be made available interactively via a new
platform for Analysis and Visualization of Omics Information (Anvi'o) created by Dr. Eren, a PI on this proposal.
The impact of the project is that it will establish a genomic, ecologic framework for understanding the oral
microbiome. It will provide a detailed, species, strain- and gene-level analysis of the oral microbiome in the
context of individual oral sites. It will identify key genes for follow-up mechanistic studies on site tropisms, niche
adaptation, and pathogenesis. It will improve authentication and error-correction of key bacterial species and
strains. The project builds on the existing strengths of HOMD, NCBI and HMP, makes available to researchers
the results of cutting-edge genomic analysis, and lays the groundwork for propelling oral microbiome research
into the pangenomic and metagenomic era.

Public health relevance
Project Justification (Project Narrative) Deciphering the interactions of microbes with each other and their host habitats is essential for understanding the oral microbiome's role in health and disease and for developing preventive and therapeutic strategies. Currently, we lack sufficient understanding of why bacteria live where they do in the mouth—such as on teeth, tongue or gums--to accomplish these goals. This proposal will close that knowledge gap using bioinformatic tools and in-depth analysis to establish a genomic, ecologic framework that will eventually enable clinicians to treat oral diseases through knowledge-based manipulation of bacterial composition.